Developing DNA-Based Molecular Robots

This proposal seeks funding to acquire state-of-the-art THUNDER Imager Model Organism
equipment that will be used to expand the scope of the funded NIH project in PI's laboratory. PI's
team plans to extend the current in-vitro studies to in-vivo, which is a significant step in achieving
PI's long-term goal of generating autonomous robots that move along the body, detect diseases,
report them, and provide therapeutics as needed. As the team’s research expands, the project's
complementary aims emerge: understanding DNA nanorobot’s endosomal escape, receptor
recognition, in-vivo circulation, distribution, metabolism, and excretion. Our team aims to include
additional studies to characterize DNA robots in more complex in-vivo environments. Therefore, the
need for a dedicated model animal imaging instrument for the project has become imminent, and
the THUNDER Imager Model Organism will enable our team to conduct these studies more
efficiently.

Public health relevance
This proposal seeks funding to acquire state-of-the-art THUNDER Imager Model Organism equipment that will be used to expand the scope of the funded NIH project in PI's laboratory.